TB Alliance CETR Administrative Core

Project Summary/Abstract: Administrative Core.
The primary objective of our Center of Excellence for Translational Research (CETR) program
is to advance translational research focused on an integrated targeting of proteostasis in
Mycobacterium tuberculosis (Mtb). The CETR will advance the development of new
therapeutics for both drug-sensitive and drug-resistant tuberculosis (TB) in the form of universal
regimens to reduce the duration of therapy and suppress the development of drug resistance.
The Center—consisting of four research projects and three scientific cores will be managed and
overseen by this Administrative Core whose main objective is to provide project management
expertise and coordination of communication, data management and the sharing of scientific
information. To achieve this objective, we have three specific Aims. Aim 1 will enhance
collaboration by providing comprehensive administrative, logistical, and scientific support to all
cores and projects. Aim 2 will promote strong collaboration through effective communication
and engagement of Center members and NIAID project scientists. Aim 3 focuses on the
creation of a website for dissemination and sharing of research project data emanating from this
Center. As the Administrative Core, TB Alliance and Research Triangle Institute will engage in
and promote collaboration across the research projects and cores to support and further the
goals of the Center program. We will leverage the strengths represented by the Center
members to accelerate translation of study findings to the scientific community by disseminating
information and maximizing scientific exchange through sharing of data, tools, protocols, and
resources.